Microenvironmental Control of Liver Progenitor Cell Differentiation and Spatial Patterning

Project Summary
The bipotential differentiation of liver progenitor cells to hepatocytes and biliary epithelial cells (cholangiocytes)
is integral to liver development, regeneration, and diseases including bile duct paucity and liver cancer. In
particular, the most common congenital liver diseases are associated with bile duct dysfunction. In addition to
the developmental processes during embryogenesis, duct morphogenesis also occurs in the adult liver in
response to severe and chronic injury. These so-called ductular reactions exhibit highly variable differentiation
patterns, and although these reactions significantly contribute to the proliferative responses in the liver, they
remain poorly characterized. Notably, ductular proliferations in the adult liver are concentrated near the portal
vein region, similar to the formation of bile ducts during development. Despite substantial research efforts, the
structural complexity and dynamic nature of liver development and regeneration has limited the comprehensive
understanding of disease mechanisms as well as the advancement of new therapeutic options. The long-term
goal of this project is to develop complementary two-dimensional and three-dimensional engineered tissue
platforms that can be applied towards the investigation of liver progenitor cell differentiation mechanisms that
are presently inaccessible with current cell culture systems and animal models. Towards this end, we will
pursue the following research objectives, which are specifically targeted towards deconstructing the combined
influence of biochemical and biomechanical signals in liver progenitor cell fate specification. In Aim 1, we will
utilize a cell microarray platform to investigate the influence of spatial gradients of Notch signaling and cell
mechanical stresses in progenitor cell differentiation. Our approach will enable the independent control of cell-
cell interactions, defined by multicellular geometry, and specific exogenous microenvironmental signals
presented within the array platform. In Aim 2, we will develop and utilize a three-dimensional microtissue
culture platform to systematically investigate the effects of three-dimensional geometry and determine how
distinct multicellular geometries regulate differentiation patterns. These research efforts will establish
microscale tissue engineering tools that enable the controlled presentation and systematic perturbation of a
range of microenvironmental signals. In Aim 3, we will extend our studies towards the direct analysis of human
liver differentiation mechanisms through the integration of human induced pluripotent stem (iPS) cell-derived
liver progenitor cells. Collectively, our approach will allow for novel studies into the mechanisms of liver
progenitor cell differentiation, including the unique examination of the combinatorial influence of cell
mechanical stress gradients and Notch signaling. Further, we envision that these platforms are generalizable,
and could be implemented as enabling technologies for fundamental biological investigation and therapeutic
development efforts for a broad range of cell and tissue contexts.

Public health relevance
Project Narrative This proposal outlines the development and implementation of microfabricated cell culture platforms that enable the convergence of engineered cell microenvironments with targeted cell signaling manipulations. This integrated approach will facilitate unique experiments focused on the spatial and temporal mechanisms governing liver progenitor cell differentiation. In addition, these platforms could be widely applicable for studies on cell fate specification, including the optimization of stem cell differentiation protocols, as well as the examination of signaling mechanisms in cancer and degenerative disorders.